Malawi Cancer Outcomes Research Program (M-CORP)

PROJECT SUMMARY
Globally, there are more deaths from cancer than from HIV, tuberculosis, and malaria combined. In 2018, there
were more than 18 million new cancer cases and 9.5 million cancer deaths worldwide, and, by 2030, these
numbers will increase by at least 50%. Countries with low or medium Human Development Index account for
more than 60% of cancer cases and 70% of cancer deaths. Cancer deaths in sub-Saharan Africa occur
disproportionately from cancers that are preventable and/or curable including lymphoma, cervical cancer and
breast cancer. Addressing the substantial burden of cancer requires a new generation of cancer
researchers who can test hypotheses in the African context. The University of North Carolina Project-
Malawi (UNCPM) has a rich cancer research environment that includes participation in the National Cancer
Institute (NCI) U54 consortium for HIV associated malignancies, the AIDS Malignancy Consortium, the
International Epidemiologic Databases to Evaluate AIDS (IeDEA), NCI African Esophageal Cancer
Consortium, and a USAID-funded cervical cancer screening study. To date, UNCPM has had significant
success in cancer clinical trials and translational research projects, and in establishing a handful of early-
career investigators, but momentum is needed to build on this foundation. First, large improvements in cancer
control in Malawi require approaches that extend beyond clinical trials to cancer outcomes research, a broader
approach that requires unique skills. At this time, there are few cancer researchers with both the necessary
cancer research skills and the local experience to develop cancer outcomes solutions adapted to the Malawian
context. Second, there is no defined pipeline for early-career cancer research capacity. Finally, there are few
opportunities for successful Malawian investigators to obtain the additional skills and experience necessary to
be competitive for independent research funding. To address these gaps, we propose to establish the Malawi
Cancer Outcomes Research Program (M-CORP). This application is led by UNC in conjunction with the
University of Malawi College of Medicine (COM) and in collaboration with other national and international
institutions and training programs. M-CORP aims to increase the cadre of trained investigators who can pursue
independent research careers by: 1) establishing a robust curriculum and training opportunities across the
continuum of cancer outcomes research specific to the Malawian environment and research priorities; 2)
supporting advanced degrees; and 3) overcoming obstacles to research independence by providing post-
doctoral opportunities including mentored pilot grants. We will use a multi-PD leadership strategy based at both
UNC and UNCPM that will optimize our strengths across the spectrum of cancer outcomes research. An
exceptional pool of multidisciplinary mentors, a detailed plan for program evaluation, and robust, broad-based
partnerships between UNC and Malawian institutions ensure that M-CORP objectives will be met and will
establish Malawi as an internationally recognized center of excellence for cancer outcomes research.

Public health relevance
Project Narrative Cancer causes more deaths globally than HIV, tuberculosis, and malaria combined, and Malawi's high burden of HIV-associated cancers provides a unique scientific setting to conduct cancer outcomes research not feasible at scale in the United States. The Malawi Cancer Outcomes Research Program (M-CORP) will train a new generation of independent cancer researchers, generating findings on HIV-associated cancer biology, treatment outcomes, and cost-effective interventions that are directly applicable to the substantial U.S. population living with HIV. Results from this program will strengthen evidence-based approaches to cancer prevention, diagnosis, and treatment that benefit Americans. HIV-associated malignancies are a leading cause of cancer morbidity and mortality among the more than 1 million people living with HIV in the United States, and a deeper understanding of HIV-associated cancer biology, treatment, and outcomes is a direct U.S. health priority. Malawi's high burden of HIV-associated cancers provides a unique scientific setting to conduct cancer outcomes research that directly informs care for Americans living with HIV, and the Malawi Cancer Outcomes Research Program (M-CORP) will train a new generation of independent cancer researchers to generate these findings. Results from this program will strengthen evidence-based approaches to cancer prevention, diagnosis, and treatment that benefit Americans.